Dissecting KRAS oncoprotein signaling with small molecule inhibitors

PROJECT SUMMARY/ABSTRACT
Small GTPases regulate diverse cellular functions and their aberrant activation plays a key role in disease.
Perhaps most signiﬁcant is their association with cancer, a disease where KRAS is mutated in ~1/3 of
patients. With this in mind, the mechanism by which cancer hotspot mutations activate KRAS is a central
concept in cancer biology. Under physiologic conditions, KRAS cycles between an active (GTP-bound) and
an inactive (GDP-bound) conformation. Its slow intrinsic GTP hydrolysis is catalyzed by GTPase-activating
proteins (GAPs). Common mutations in KRAS prevent the stabilization of the hydrolysis transition-state
leading to oncoproteins that are thought to be deﬁcient in hydrolysis, insensitive to GAPs, and constitutively
active in cancer cells (i.e., `locked' in their active or GTP-bound, state). Emerging therapies are challenging
the conventional model of KRAS oncoprotein activation. Perhaps the strongest evidence is provided by
inhibitors selectively targeting KRAS G12C, the most common KRAS mutation in lung cancer. G12C inhibitors
bind only to the GDP-bound (or hydrolyzed) conformation and trap the oncoprotein in an inactive state by
preventing the exchange of GDP for GTP. To be eﬀective, these inactive state selective drugs require intact
GTP hydrolysis by mutant KRAS. In a similar fashion, inhibition of nucleotide-exchange (as achieved by
targeting factors upstream of KRAS) has been reported to suppress mutant KRAS activation and/or tumor
growth. This and other emerging therapeutic eﬀects presented in the preliminary data of this application could
not be possible if mutant KRAS GTPases were `locked' in their active state. Our proof-of-principle
experiments suggest the presence of cellular proteins that enhance the GTPase activity of mutant KRAS and
that KRAS oncoproteins are broadly susceptible to inactive state selective inhibition. We now propose (i) to
isolate enhancers of mutant KRAS GTPase activity in cancer cells, (ii) to determine the tertiary structure of
common KRAS mutants in complex with their enhancer and (iii) to characterize the eﬀects of novel inactive
state selective drugs that suppress common KRAS mutants found in cancer. This work will explain the
mechanistic basis responsible for the physiologic inactivation of mutant KRAS and reﬁne the conceptual
model explaining how mutations activate KRAS in cancer. The proposed study will pave the way for key
advances in cancer biology with a large potential for therapeutic and translational impact in patients.

Public health relevance
PROJECT NARRATIVE Deciphering the effect of mutations on the function of normal cellular enzymes is imperative for a better understanding of how cancer and other diseases occur. KRAS, a small enzyme that breaks down the nucleotide guanosine-5'-triphosphatate to guanosine diphosphate, is altered in nearly a third of patients with cancer. The proposed work will identify proteins that physiologically inactivate mutant KRAS and provide fundamental new insight for cancer biology and therapy.